Cocaine-induced adaptation in NMDA receptors

Abstract
During drug abstinence, re-exposure to cues previously associated with cocaine often trigger drug relapse. In
rodent models of cocaine seeking and relapse, animals that self-administer cocaine in the presence of
contingent cues often establish a strong association between cues and cocaine, such that after drug
withdrawal, the presence of cues induces strong cocaine seeking. Cue-induced cocaine seeking is extremely
long-lasting and intensifies progressively after withdrawal. The goal of this application is to develop new
concepts and approaches through which the cue-cocaine association can be disrupted to reduce cocaine
relapse. The cue-cocaine association that drives cocaine seeking shares general features of cue-conditioned
memories. Similar to classic conditioning memories, cue-conditioned drug memories also undergo a
destabilization and reconsolidation process after retrieval. During the brief destabilization time window,
amnesic treatments are often more effective in reducing subsequent cue-induced cocaine seeking. However,
the neural substrates that mediate cue-drug memory retrieval and reconsolidation remain elusive. Targeting
this knowledge gap, this application focuses on cocaine-generated silent synapses and their dynamic changes
within the basolateral amygdala (BLA) to nucleus accumbens (NAc) projection. We recently showed that
cocaine self-administration generates silent synapses in the BLA-to-NAc projection. Silent synapses are
excitatory synapses that contain NMDA receptors without stable AMPA receptors (AMPARs). Our additional
results suggest that cocaine-generated silent synapses may serve as the initial hubs to establish a potentially
new set of circuits. After cocaine withdrawal, BLA-to-NAc silent synapses become `un-silenced' by recruiting
calcium-permeable AMPARs (CP-AMPARs), resulting in consolidation of the silent synapse-imbedded circuits.
Reversing the un-silencing of BLA-to-NAc silent synapses decreases cue-induced cocaine seeking. These
results suggest that the newly formed, silent synapse-embedded BLA-to-NAc projections contribute to the
establishment and subsequent consolidation of cue-cocaine association. Based on extensive preliminary
results, we hypothesize that after cocaine withdrawal, a brief re-exposure to cocaine-associated cues instantly
induces CP-AMPAR internalization and re-silences the same set of BLA-to-NAc silent synapses that are
generated by cocaine self-administration, contributing to the destabilization of cue-cocaine association. These
re-silenced synapses are un-silenced again by re-recruiting CP-AMPARs hours after cue re-exposure,
contributing to reconsolidation of cue-cocaine association. We will use electrophysiology, optogenetics, in vivo
calcium imaging, viral-mediated gene transfer, and operant behavioral assays to test this hypothesis. By
accomplishing the proposed work, we may identify a cellular and circuit basis underlying destabilization and
reconsolidation of cue-cocaine association after retrieval and validate therapeutic angles to reduce cocaine
relapse. Thus, objectives of this application are highly relevant to the missions of the NIDA, NIH.

Public health relevance
Narrative: Cue-induced cocaine seeking precipitates cocaine relapse, which is partially mediated by generation and subsequent maturation of AMPA receptor-silent excitatory synapses within the amygdala-to-accumbens projection. The proposed work will test the hypothesis that upon cue re-exposure after cocaine withdrawal, matured silent synapses become re-silenced and destabilized for ~6 hours within this projection, thus providing a manipulation window to disrupt the cue-cocaine association and decrease cue-induced cocaine relapse. The expected outcomes of this proposal will provide a circuitry-based understanding of cue-induced cocaine relapse and a set of targetable substrates for clinical treatment of cocaine addiction.